Career Development and Mentoring Core

The CEEH is committed to nurturing the next generation of ecogenetics researchers by ensuring that the University of Washington recruits, supports, and retains a new generation of high-caliber EHS-focused investigators with a strong interest in gene-environment interactions. To this end, we propose to establish a new core, the Career Development and Mentoring Core (CDMC).